Evaluating the mechanisms of cell free fetal DNA signaling in the promotion of labor

PROJECT SUMMARY
Parturition is a highly inflammatory event characterized by an upregulation of pro-inflammatory cytokine
production, maternal leukocyte activation, and cellular infiltration into the uterus. However, untimely
inflammatory triggers may shift the maternal immune system towards the transition to labor early, such as in
cases of preterm birth (PTB). Currently, the mechanisms involved in the switch to a pro-inflammatory state and
parturition initiation is largely unknown. Evidence supports circulating damage-associated molecular patterns
(DAMPs) in the maternal blood, such as cell-free fetal DNA (cffDNA), may trigger sterile inflammation and labor
through activation of maternal innate immune cells. cffDNA is continuously released from the placenta into the
maternal bloodstream with concentrations steadily increasing as pregnancy progresses, becoming
undetectable hours after parturition. Importantly, cffDNA is abnormally elevated in pathological pregnancies,
including PTB. The Enninga lab showed cffDNA, but not cell-free DNA (cfDNA), can activate maternal
monocytes through cGAS/STING to initiate hallmark processes of parturition; however, the mechanism of
cffDNA activation or why it is a potent immunostimulatory molecule remains incompletely understood. This F31
proposal seeks to evaluate whether inhibiting the cGAS/STING pathway can reduce CD14+ monocyte
activation and the pro-inflammatory cascade following cffDNA recognition (Aim 1) and identify the
immunostimulatory properties of cffDNA specific sequence motifs (Aim 2). Completion of these studies will
provide better understanding of the immunological processes driving labor at term. Additionally, it may provide
a novel small molecule target that could be tested clinically for dampening systemic maternal immune
activation, which would be especially important for PTB prevention. This award will provide Raini Sorenson
with individualized, mentored training from excellent faculty sponsors while working on dissertation research in
immunology. Furthermore, this training award will facilitate Raini’s development into a strong applicant for a
competitive post-doctoral position.

Public health relevance
PROJECT NARRATIVE Human labor is a highly inflammatory event, but what causes it to start is unclear. We have found that cell-free fetal DNA (cffDNA) can activate the mother’s immune system and promote the transition towards labor. This proposal aims to understand what about cffDNA makes it activate immune cells and whether we can block the inflammation caused by cffDNA, which is particularly important for preventing preterm birth.